Optimization of Tannic Acid Lipid Nanoparticles for a Therapeutic mRNA Vaccine Against Melanoma

ABSTRACT
Melanoma is the deadliest form of skin cancer. The FDA-approved immune checkpoint inhibitors
targeting PD1 and CTLA4 and the targeted therapies against BRAF and MEK have greatly improved overall
survival in metastatic melanoma. Nevertheless, many patients die from metastatic melanoma including those
with inflamed tumors (i.e., tumors bearing tumor-infiltrating lymphocytes). There is therefore room to improve
melanoma treatments for human patients.
Here we propose the development of therapeutic mRNA vaccines against melanomas. Specifically, our
proposal leverages a materials optimization approach to identify an Optimized Tannic Acid Lipid Nanoparticle
Formulation that can suppress melanoma growth by delivering mRNAs encoding Melanoma-Associated
Antigens into Dendritic Cell Populations. In undertaking this approach, this proposal aims to further our
understanding of the mRNA delivery capabilities of Tannic Acid Lipid Nanoparticles while simultaneously laying
the groundwork to advance therapeutic mRNA vaccines against melanomas toward the clinic.

Public health relevance
PROJECT NARRATIVE Melanoma is the deadliest form of skin cancer and new treatments are needed to improve patient survival. Here we propose the development of therapeutic melanoma vaccines that train the immune system to recognize and destroy melanoma cells using my lab's unique mRNA delivery platform termed Tannic Acid Lipid Nanoparticles.